The Experimental Tobacco Marketplace (ETM)

PROJECT SUMMARY/ABSTRACT The goal of tobacco regulations is to improve public health. Tobacco regulations, however, are often implemented before they have been tested in a research setting, thereby increasing the likelihood of untoward effects caused by such regulations. The goal of this project is to use the Experimental Tobacco Marketplace to empirically assess the effects of regulatory changes on tobacco consumption among smokers. The specific aims will address how factors such as dose, price, environmental constraints (smoke-free work environments), and flavors affect consumption and substitutability of cigarettes and vaporized nicotine products. In these within-subject studies, the research team will examine choices in the Experimental Tobacco Marketplace with some purchases actualized. This novel method will increase the external validity of modern regulatory science. Moreover, the obtained results will help direct policymakers' decisions about the availability and pricing of alternative, potentially less harmful, tobacco products.

Public health relevance
PROJECT NARRATIVE The number one preventable cause of mortality and morbidity in the US is cigarette smoking. Identifying policies to reduce or eliminate smoking should therefore be a primary goal of regulatory science. The overall goal of this project is to experimentally assess the factors that influence tobacco consumption and consumer behavior. Testing proposed policy changes, such as restrictions on vaporized nicotine product use, in a laboratory setting before enacting them will help to identify any untoward, unanticipated effects and bolster the successful implementation of such policies within society.